Microenvironmental regulation of breast tumorigenesis

PROJECT SUMMARY
The tissue microenvironment dictates adult stem cell behavior during normal homeostasis and cancer. The
microenvironment of the breast contains numerous distinct cell types including basal and luminal mammary
epithelial cells that form a ductal network surrounded by stromal cell types such as adipocytes and fibroblasts.
One of the key regulators of the tumor microenvironment are the matrix metalloproteinases (MMPs), which are
secreted proteolytic enzymes that affect multiple aspects of cancer including extracellular matrix remodeling,
inflammation, and metastasis. MMPs have been implicated in breast cancer for many years and they have
been considered as therapeutic targets to treat cancer patients. However, previous clinical cancer trials using
synthetic small molecule inhibitors to interfere with MMP catalytic activity yielded disappointing results. Our
previous research has shown that MMPs such as MMP3 may work in a non-proteolytic manner through their
hemopexin domain. This may explain why compound inhibitors targeting the catalytic function of MMPs failed
to improve disease outcome.
Here, we will focus on the role of stromal fibroblast-derived MMP3 and its interaction with the non-
canonical Wnt signaling pathway during BRCA1-related breast cancer initiation. In our previous work, we have
established that MMP3 can modulate the non-canonical Wnt signaling pathway by binding and inactivating
Wnt5b via the hemopexin domain and that this plays an important role in stem cell maintenance during normal
homeostasis of the mammary epithelium. We will now determine whether this interaction of MMP3 with Wnt5b
affects breast cancer initiation. In particular we will employ lentiviral transduction, transplantation of mammary
epithelial cells, mouse models of breast cancer in combination with cutting single cell genomics and multi-
modal imaging tools to address whether (1) fibroblast-derived MMP3 promotes pro-tumorigenic changes in
breast epithelial cells in vitro and in vivo in a potentially non-proteolytic manner, (2) Wnt5b is the critical
substrate mediating the tumor-promoting effects associated with MMP3, (3) Wnt5b specifically regulates
mammary stem cell proliferation and exerts tumor suppressing effects within the breast epithelium. Taken
together, these studies will unravel new molecular mechanisms through which the microenvironment promotes
tumor initiation, and yield a better understanding of the non-canonical Wnt signaling pathway in regulating
normal epithelial homeostasis and breast cancer initiation. Ultimately, our work may implicate the
MMP3/Wnt5b axis as a potential therapeutic target for primary cancer prevention in BRCA1 mutation carriers.

Public health relevance
PROJECT NARRATIVE Breast cancer arises from breast epithelial cells that gather pro-tumorigenic mutations leading to uncontrolled cell proliferation and tumor initiation. Knowledge of how tumor initiation can be regulated by the cellular microenvironment will enable us to specifically interfere with the function of tumor-initiating cells to stop tumor growth and potentially recurrence of breast cancer. Here, we will focus on matrix metalloproteinases (MMPs), and study how these extracellular proteases are involved in the regulation of normal homeostasis and BRCA1-related breast cancer initiation by orchestrating the Wnt signaling pathway. This may lead to the development of novel therapeutic approaches for primary cancer prevention and to treat patients suffering from breast cancer.